BATF as an inducible regulator of natural killer cell expansion and effector function

Project Summary:
Natural killer (NK) cells exist in a chronically “primed” state that facilitates rapid cytokine
production, chemokine-mediated dendritic cell and macrophage recruitment, and direct target
elimination. These cells play a pivotal role in protection against -herpesviruses and
coronaviruses, and in the immune response against metastatic tumors and leukemia. Emerging
evidence supports an important role for NK cells in the initiation of the immune response against
some solid tumors. While NK cell survival and function can be suppressed in the tumor
microenvironment, these cells can be restored by environmental manipulation or checkpoint
blockade therapy. These findings raise the possibility that NK cells, if manipulated appropriately,
could have therapeutic benefits in multiple disease contexts including in solid tumors. Therefore,
a comprehensive understanding of the mechanisms controlling NK cell survival, proliferation, and
effector function in different disease contexts is needed. In this grant, we present preliminary data
identifying BATF as a transcription factor induced by the proinflammatory cytokine IL-12, which is
responsible for the priming of NK cells during their development and for NK cell expansion in
response to viral infection. We will test the consequences of altered BATF expression, both loss
and gain of function, on NK cell maturation and anti-tumor immunity (Aim 1) and the NK cell
response to viral infection (Aim 2). We propose a comprehensive characterization of BATF target
genes and the impact of BATF on chromatin accessibility, histone modification, and functional
output. Taken together, these studies will provide a broad view of the requirements for BATF and
the potential for modulating BATF or its target genes for therapeutic intervention in anti-viral and
anti-tumor immune responses.

Public health relevance
Narrative: NK cells play an important role as the first line of defense against some viral infections and metastasis, and recent data reveal that they can be therapeutically useful in the immune response to solid tumors. A better understanding of the transcriptional programs that control NK cell survival, expansion, and effector functions is needed to harness the potential of these cells in therapeutic contexts. This grant aims to fill the gap in knowledge of how BATF, a major cytokine- induced transcription factor, controls NK cell gene programs in multiple pathogenic contexts.